Membrane lipid regulation of calcium channels in sperm.

PROJECT SUMMARY
Voltage-­gated calcium channels (VGCC) regulate the function of cells ranging from sperm to insulin-­producing
pancreatic cells to neurons. There is growing recognition that specific lipids, sterols and the ganglioside GM1,
regulate VGCC activity in health and disease including during fertilization, regulation of blood sugar, and pain
sensation. However, determining mechanisms by which lipids regulate VGCC remains a major challenge in the
field. This proposal addresses two questions of broad importance to biology & medicine: At a molecular level,
how can membrane lipids regulate 1) VGCC activity and 2) cell function? Sperm are an outstanding model for
these issues, because their ability to fertilize an egg is well-­known to be regulated by lipid dynamics. However,
there is tremendous controversy regarding sperm calcium (Ca2+) channels, with electrophysiological recordings
(at room temperature) only identifying the activity of a single, non-­VGCC channel (CatSper). In contrast, data
from several groups using approaches of cell biology, genetics and pharmacology, show the activity of different
channels including VGCC. Of importance, we found that sterols and GM1 regulate sperm VGCC activity in ways
that typical electrophysiology practices can’t detect. This proposal represents a consortium of two laboratories,
one with expertise in sperm electrophysiology, who have pioneered new methods to be able to detect channels
regulated by lipids. The second laboratory was first to identify membrane lipid regulation of sperm VGCC, and
has expertise in membrane lipid organization and function. Together, we propose to use new technologies and
approaches to address this controversy, which is central to our understanding of sperm function & fertilization.
This knowledge will empower clinicians to better understand the causes of male infertility, half of which are due
to sperm function defects and are not detected by traditional semen analysis. Based on exciting preliminary
data that clearly show evidence of more than one type of Ca2+ channel (using sperm from mice null for
CatSper), as well as publications from both laboratories, we propose a series of experiments to investigate
how lipids regulate mouse and human sperm VGCC and possibly other Ca2+ channels (Aim 1). These studies
will utilize state-­of-­the-­art microscopy, pharmacology, mouse genetic models and electrophysiology under
conditions that allow sperm membrane lipids to behave as they do in the female reproductive tract. We next
propose to determine the precise molecular mechanisms by which sterols and GM1 regulate VGCC (Aim 2). To
do this, we’ll express different VGCC subunits in specific cell lines, as well as artificial membrane systems, in
which we can control both channel expression and the lipid composition. In both Aims, we will utilize innovative
mouse strains either expressing genetically encoded Ca2+ indicators or lacking specific channel subunits.
Together, these studies will provide broad mechanistic insight into the regulation of VGCC by membrane lipids,
a matter of critical importance in both normal physiology as well as important disease states.

Public health relevance
PROJECT NARRATIVE Sterols and GM1, lipids in the sperm plasma membrane, regulate the voltage- gated calcium channel, CaV2.3—a critical regulator of exocytosis and function in cells ranging from sperm to pancreatic beta cells to neurons. Results show that this form of regulation is critical for sperm to be able to fertilize;; however, these results have been made controversial by commonly used electrophysiology approaches that fail to identify any calcium channel activity other than that of the CatSper channel. This collaborative proposal uses cutting- edge electrophysiological approaches and novel mouse models to resolve these controversies and explore the molecular mechanisms by which these lipids regulate CaV2.3 and cell function, with important applications to not only infertility, but also diabetes, peripheral neuropathy and pain.